Core C. External Innovative Network Core

OTHER PROJECT INFORMATION – Project Summary/Abstract
Core C – External Innovative Network Core
The external innovative network core creates opportunities and encouragement for investigators working on
similar research themes at different universities to meet, communicate, brainstorm, collaborate and plan for the
continuing development of their collective research agenda. The network core is organized around the five major
themes of Center research, which evolve with the research priorities of Center investigators and leadership. The
networks involve teams of investigators from existing NIA-funded projects, Center pilot projects, and others, who
come together to draw from the collective activities and expertise of the group. Meetings and conferences of
varying size are convened for the purpose of stimulating this exchange. Particular attention is paid to the
networks dealing with research themes that are high priorities for new research development. The activities of
the network core are exemplified by recent or upcoming meetings on Machine Learning in Health Care; The
Economics of Alzheimer’s Disease and Related Dementias; Adult Mortality in the 21st Century; International
Comparisons of Income and Life Expectancy; Pain: Measurement, Causes and Consequences; Determinants
of Life Expectancy by Income and Geography; the Measurement and Tracking of Subject Wellbeing; and Native
American Health and Health Care.